Citizen DNA Barcode Network: A Community-based Infrastructure for Monitoring Biodiversity and Disease Vectors

In collaboration with the New York Hall of Science (NYSCI), the DNA Learning Center
(DNALC) of Cold Spring Harbor Laboratory (CSHL) proposes to develop a Citizen DNA
Barcode Network. The project will organize national campaigns to map the ranges of
species within three groups of insect: ants, mosquitoes, and beetles. These groups
include bioindicators of environmental change, vectors of human disease, and
economically important species whose ranges are being altered by global climate change.
Citizen scientists will use the technique of DNA barcoding, which allows non-experts to
identify almost any insect species, even from larval forms or damaged samples.
The project is based on an integrated biochemical and bioinformatics workflow we have
developed to support DNA barcoding in formal education settings. Our current SEPA
project, Barcode Long Island, has undertaken DNA barcoding campaigns in the formal
education system—with high school students documenting local biodiversity and the
northward range expansion of several insects—novel evidence of global warming.
During the development phase, we will work intensively with NYSCI to refine resources
and dissemination methods to support citizen science in informal settings. In parallel, we
will pilot methods to engage visitors to nature preserves and members of conservation
groups, including The Nature Conservancy and Audubon Society. During the replication
phase, we will onboard three additional science centers and six additional community
conservation groups. Partners will be provided with training, educational materials, mobile
labs, and supplies needed to generate data for insect campaigns and biodiversity surveys
(bioblitzes) of locally important habitats. Mentorship by high school and college faculty with
experience in DNA barcoding and extended collaborative support—including
troubleshooting and data analysis—will help insure success at each site.
Data collected by citizen scientists will contribute to the scientific record in two ways: 1)
Barcode sequences will be published in GenBank, the authoritative DNA database, and to
species-specific databases. 2) Occurrence data will be contributed to the Global
Biodiversity Information Facility (GBIF) to expand existing range maps. A multi-faceted
evaluation program will develop novel survey instruments to assess the impact of
participation in citizen barcoding projects on attitudes toward biodiversity on global
climate change.

Public health relevance
PROJECT NARRATIVE This project will adapt methods from our current SEPA project to establish DNA barcoding for use in informal settings. Our objective is to equip visitors to science centers and nature preserves and members of community conservation groups to inventory species in local habitats. These citizen scientists will contribute new information to global biodiversity databases and improve range maps that show how species are responding to environmental change.